The neural basis for aging-dependent decline in taste function

PROJECT SUMMARY
Deficits in chemosensory processing are associated with healthy aging, as well as numerous neurodegenerative
disorders including Alzheimer’s Disease (AD). In many cases, chemosensory deficits are harbingers of
neurodegenerative disease, and understanding the mechanistic basis for these changes may provide insight into
fundamental dysfunction associated with aging and neurodegeneration. The genetic and physiological
accessibility of chemosensory neurons and their defined higher order processing centers provide a unique
opportunity to investigate the effects of aging-related processes on neural function, including sensory
responsiveness, plasticity, and synaptic connectivity. The fruit fly, Drosophila melanogaster, is a powerful model
for studying chemosensation, aging, and aging-related pathologies, yet the effects of aging on chemosensation
remain largely unexplored in this model, particularly with respect to taste. A large genetic toolkit combined with
functional imaging allow for cell-type specific manipulation of taste circuits. Numerous models of AD been
developed in Drosophila that largely phenocopy two hallmarks of AD: amyloid beta (Aβ)-mediated toxicity and
tauopathy caused by hyperphosphorylation of the Tau protein. My preliminary findings reveal that taste
perception and taste memory deteriorate with age, and this is exacerbated in a fly model of AD. Here, I will
examine the physiological and molecular basis for age-associated reduction in taste and taste memory in models
of natural and pathological aging. These experiments build on my expertise in chemosensory processing and
functional imaging, while providing training in aging and genomic approaches.

Public health relevance
PROJECT NARRATIVE Deficits in chemosensory processing are associated with normal aging as well as numerous neurodegenerative disorders including Alzheimer’s Disease (AD). This proposal will investigate how taste processing and taste memory are affected by aging and AD. A functional investigation into the mechanisms regulating age- and AD- associated decline in taste and memory will further our understanding chemosensory processing, aging, and neurodegenerative disease.